Resource and Service Section

PROJECT SUMMARY RESOURCE AND SERVICE CORE
The overall goal of the Resource & Service Core is to publicize the mouse models and services developed
through the JCPG and to distribute these models to the broader scientific community. To accomplish this goal,
the Resources and Services Core will work closely with the Bioinformatics Core in the continuous development
of the JCPG website for the dissemination of information related to the JCPG. The distribution of mice will
leverage the existing mouse breeding, cryopreservation, biosecurity and quality assurance infrastructure at The
Jackson Laboratory (JAX) as well as the existing NIH-funded Mutant Mouse Resource and Research Center
(MMRRC) for a seamless transition of models from the core to the community. The Core will add new services
and refine existing services to add to the existing fee for service program that operates in professional service
environment, with customer quotes, project execution, deliverables, finalized reports and feedback. JAX has a
95-year history of developing, archiving, and distributing laboratory mice, and their derivative resources and
information, to the scientific community. The JCPG will complement and expand resource stewardship at JAX
by leveraging the deep expertise of JAX researchers and services. JAX is seeing a predictable demand for model
generation services as a result of CRISPR/Cas9 genome editing technologies and the reduction in costs for
patient sequencing. This, in turn, has increased the demand for phenotyping and ancillary services, such as
behavioral assessments, histology, gene expression, proteomics, microscopy, etc. that can be tailored for each
disease model. With the continuous advancement of gene-based therapies, the JCPG will help to satisfy the
additional external need for pharmacology, safety and efficacy-based preclinical testing in mice. Operation of the
JCPG Resource and Service Core will serve to: 1) Provide new mouse models to the scientific community,
following well-established processes for rigor, quality assurance and customer service. Mice generated by the
Disease Modeling Unit (DMU) will pass seamlessly through our customer service and production infrastructure
to the JAX-MMRRC repository for maintenance, distribution and preservation. Each step of the process will be
facilitated by tools and processes developed by the Bioinformatics section of the JCPG. 2) Refine existing and
consider new key JAX services with input from our clients and make them available to the biomedical community
on a fee-based mechanism with a focus on maximizing awareness and external availability using existing JAX
outreach and marketing infrastructure and efforts. 3) Develop an integrated management and operational
structure that weaves together core services and delivers them as efficiently as possible. Successful
implementation of the Resource/Services core depends on our experienced management team to integrate
individual service cores into a seamless program.